Administrative Core

PROJECT SUMMARY – CORE A
The overall function of Core A is to support Dr. Sorrentino in his role as overall Principal Investigator of the
program by defining a chain or responsibility upon which the PPG is organized and establishing connectivity
and communications between the various projects and participating centers. Core A will provide a closely
interacting network of experienced administrators who work directly with the Project and Core leaders at St.
Jude, the Children's GMP LLC in Memphis, Seattle Children's Hospital, intramural National Institutes of Health
(NIH), Boston Children's Hospital, and University of California at San Francisco (UCSF). To do this, Core A will
provide budgetary oversight and accounting for yearly grant expenditures, administrative support and
organization for monthly teleconferences, assistance in preparation of progress reports and competitive
renewal applications, and support for PPG-related travel and conferences. Core A will also support the
External Advisory Board visit that will provide scientific review and advice for each of the various components
and provide formal feedback following a site-visit review at the end of the third year of the upcoming cycle.
Overall, Core A is an essential backbone for this multisite program project grant and will ensure seamless
administrative and scientific interactions, particularly with the St. Jude Cores and external investigators.